Developmental Funds

PROJECT SUMMARY: Developmental Funds
Mindy Roberts, M.A., Associate Director of Administration
Developmental funds are used to shape and implement the vision of the Knight Cancer Institute (KCI). Controlled
by the KCI Director and derived from cancer-focused philanthropy, OHSU institutional commitment, and support
from the CCSG, these funds are critical to the KCI strategic planning and success. During the past reporting
period, we have invested a total of $108 million in our four Research Programs [i.e., $6.5 million in Cancer
Biology, $11.8 million in Cancer Prevention and Control, $28.2 million in Quantitative Oncology, and $61.6 million
in Translational Oncology), resulting in recruitment of 56 new members, 12 of whom are senior leaders. The
return on investment in recruitments over the current reporting period has yielded a total of $113 million in
external funding, of which $73.5 million is peer-reviewed.
Investment of $3.1 million in 78 pilot project awards from FY2015 through FY2019 resulted in $51.1 million in
peer-reviewed funding and a total of 287 publications. Development funds enabled the KCI to enhance our
Shared Resources available to cancer researchers, with a total investment in Shared Resources equipment,
upgrades, and staffing of $11.6 million in the current reporting period.
We will continue to use Development funds to support the recruitment of researchers and clinician-scientists in
support of our KCI Strategic Plan and to support ongoing excellence in each of the four KCI Research Programs.
We will continue to provide pilot project funding to facilitate inter-programmatic collaborations and the generation
of preliminary data to support the development and submission of peer-reviewed funding applications.